Nanoscale assembly of amyloid oligomers at physiologically relevant conditions

According to numerous in vitro studies, formation of amyloid beta (Ab) and other amyloidogenic protein is a self-assembly
process that results in the production of neurotoxic oligomeric aggregates along with fibrillar structures, a hallmark of
diseases such as Alzheimer’s disease. However, the vast majority of in vitro studies are performed at Ab concentrations of
several orders higher than the physiologically relevant concentrations of Aβ in the brain; no aggregation of Aβ is observed
at the low nanomolar concentration found in vivo. This suggests that the assembly of Aβ in aggregates in vivo utilizes
pathways different from those used in experiments in vitro. We discovered that spontaneous assembly of Aβ42 oligomers
from monomers within the physiologically relevant concentration range can occur by utilizing the on-surface aggregation
mechanism. Here, the surface acts as a catalyst for the aggregation process. We developed a model that explains the surface
catalytic effect of the amyloid aggregation from monomers at low nanomolar concentrations. Our central hypothesis is that
the self-assembly of Aβ oligomers is initiated by the interaction of amyloid proteins with the cellular membrane. The
membrane effectively catalyzes amyloid aggregation by stabilizing aggregation-prone conformations of amyloids. A
thorough testing of this hypothesis is the major goal of this application. The rationale for the proposed goal is that
understanding the fundamental mechanisms of membrane-mediated aggregation will guide the development of practical
approaches to control the aggregation process. The objective of this proposal is to characterize the on-surface formation of
Aβ oligomers, identify the aggregation-prone composition of cellular membranes, and develop a molecular model for future
use in translational studies. Guided by strong preliminary data, we will test our central hypothesis through the following
three specific aims: Aim 1: Characterize the aggregation process of Ab monomers catalyzed by cellular membranes with
different lipid compositions. Aim 2: Evaluate contributions of free lipids of cell membranes into the membrane catalysis of
amyloid aggregation. Aim 3: Develop a molecular model for the membrane catalysis phenomenon using theoretical and
computational approaches. Aim 1 is focused on testing our hypothesis that the lipid composition of the membrane bilayer
is the defining factor in spontaneous aggregation of Ab proteins at physiological concentrations. Under Aim 2, we will test
the hypothesis that free lipids contribute further to the membrane catalysis of amyloid aggregation. Aim 3 proposes the use
of theoretical approaches and high-power computer modeling to gain structural insights into the molecular mechanism
behind catalysis of aggregation by the cellular membrane. The predictions of the theory will be tested under Aims 1 and 2,
and the experimental results obtained from these Aims will be further used to tune the theoretical methods. The proposed
research plan, combining experimental studies with extensive computational modeling, will provide a molecular model for
the aggregation process catalyzed by membranes at physiological concentrations of monomers. The development of
potential preventions for the interaction of monomeric amyloids with membrane can help to control the aggregation process.
This is a paradigm shift, which opens prospects for the development of efficient treatments, early diagnostics, and preventive
therapies for Alzheimer's disease.

Public health relevance
The work proposed is relevant to public health given its focus on unraveling molecular mechanisms of Alzheimer’s disease that can be extended to other neurodegenerative diseases. The proposed research will help to explain how the disease-prone protein aggregates appear and develop, which in future studies will help to develop approaches controlling the aggregation process. Thus, the proposed research is relevant to the NIH’s mission pertaining to developing fundamental knowledge that will improve preventive and therapeutic treatments for diseases.